Administrative Core

The Administrative Core of the University of Massachusetts, Boston (UMass Boston) and Dana-Farber/Harvard Cancer Center (DF/HCC) Partnership takes an integrated approach to operational structure to support the growth of broad-based, transdisciplinary cancer and cancer disparities research at both institutions. Partnership PIs Drs. K “Vish” Viswanath and Gregory “Goyo” Abel from DF/HCC and Drs. Adán Colón-Carmona and Jill Macoska from UMass Boston, lead the Administrative Core and provide complementary expertise and abiding dedication to the sustained success of this research program. As the nucleus of the leadership and administrative teams, the PIs, with the support of effective internal (Internal Advisory Committee (IAC)), external (Program Steering Committee (PSC)) and institutional leaders, provide rigorous oversight for the research projects, programs, and Cores, to maximize the impact of the Partnership at the institutional level. In addition, a single Partnership Program Manager shared by both institutions creates operational synergies in the management of this multi-institutional research collaboration.
The aims of the Administrative Core are to: 1) Provide administrative and fiscal oversight for Partnership cores and research projects, and ensure responsible stewardship of funds; 2) Coordinate joint Partnership activities at UMass Boston and DF/HCC and facilitate networking opportunities; 3) Ensure proper infrastructural support for funded projects and cores; 4) Manage Partnership communications with all critical stakeholders in greater Boston; 5) Support an institutionally-funded Research Project Manager who will leverage the expertise of the Partnership Cores to begin to investigate reasons for faculty attrition, train a dedicated group of mentors for before and after hire, and develop a new network for post-docs in the Boston metro area; and 6) Track institutional commitment in support of Partnership initiatives, particularly toward recruitment efforts for Early Stage Investigators and leverage institutional resources for this effort.

Public health relevance
The Administrative Core is the foundation upon which all Partnership activities are built. Led by the four MPIs and the Partnership Program Manager, this core will serve the Partnership by ensuring all participants are communicating well, know how to best to leverage Partnership resources, and understand how to best meet their obligations.